Basis for Lineage-Specific Control of PTEN Expression by Rpl22

DESCRIPTION (provided by applicant): Ribosomal proteins are vital to multiple aspects of cellular function and survival. Mutations in ribosomal structural proteins or in proteins regulating ribosome assembly severely disrupt hematopoiesis in the bone marrow1,2;however, such mutations have not yet been found to selectively disrupt T-lineage cells. Ablation of the gene encoding the ribosomal structural protein Rpl22 results in a strikingly specific defect in T cell development. This proposal seeks to understand the basis for the lineage restriction of the developmental blockade in Rpl22-deficient (Rpl22-/-) mice. Rpl22 is a ubiquitously expressed RNA binding protein that is a component of the 60S ribosomal subunit but is not essential for global or CAP-dependent translation3, 4. Surprisingly, Rpl22-/- mice are healthy, fertile, and of normal size. However, our laboratory finds that ablation of the Rpl22 gene in mice results in a blockade in thymic development of ?? lineage but not ?? lineage T cells5. We have reported that Rpl22-mediated de-repression of p53 translation occurs specifically within the ?? T cell lineage but not in the closely related Rpl22-/- ?? lineage cells. In this proposal, I will define the basis for the lineage-restricted p53 induction through an analysis of the tumor suppressor phosphatase and tensin homolog deleted from chromosome 10 (PTEN). Preliminary data indicate that PTEN expression in Rpl22-/- DN thymocytes (a mixed population of ?? and ?? precursors) is markedly reduced. Subsetting the DN thymocytes into ?? lineage DN3 and ?? precursors revealed that p53 induction occurred in Rpl22-/- ?? lineage cells that retained PTEN expression, but not in Rpl22-/- ?? lineage cells which had lost PTEN expression. I hypothesize that differences in PTEN levels in Rpl22-/- ?? and ?? lineage cells will influence their sensitivity to Rpl22-deficiency because PTEN is a positive regulator of p53. The experiments proposed within this application will determine the mechanism for differences in PTEN expression between ?? and ?? lineage cells in Rpl22-/- mice via p53 regulation. In specific aim 1 of my proposal, will examine the mechanism of PTEN regulation between Rpl22-/- ?? and ?? lineage T cells. I will investigate the level of PTEN expression in Rpl22-/- ?? and ?? T cell populations and then determine whether Rpl22 deficiency controls PTEN expression at the level of mRNA, protein synthesis, or protein stability. Moreover, based on my findings, I will investigate the mechanistic basis for the effect in part by determining if lineage-specific differences exist in known regulators of PTEN transcription6, 7, translation8, or protein stability9, 10. Given that Rpl22-/- ?? lineage cells retain PTEN expression, and thus are subject to a block in development due to translational de-repression of p53 mRNA means that PTEN ablation should reduce p53 levels and allow development to continue. In Specific Aim 2, I will use loss-of-function approach by deleting PTEN specifically from T lineage cells and analyze the effects on ?? lineage cell development. Together this proposal will provide insight into the mechanisms for ?? T cell resistance to Rpl22 deficiency, and potentially into a novel role for p53 regulation. PUBLIC HEALTH RELEVANCE: The extraribosomal functions of ribosomal proteins, such as in regulating cell death, inflammation, and cell cycle, have far-reaching and biologically important consequences. My research will reveal the basis for ribosomal protein Rpl22-mediated regulation of the tumor suppressor protein PTEN, and potentially determine why Rpl22 deficiency imposes a developmental blockade on a major T lymphocyte lineage. My proposal seeks to further our understanding of Rpl22 in these processes which will potentially lead to therapeutic targets of cancer or inflammation.

Public health relevance
The extraribosomal functions of ribosomal proteins, such as in regulating cell death, inflammation, and cell cycle, have far-reaching and biologically important consequences. My research will reveal the basis for ribosomal protein Rpl22-mediated regulation of the tumor suppressor protein PTEN, and potentially determine why Rpl22 deficiency imposes a developmental blockade on a major T lymphocyte lineage. My proposal seeks to further our understanding of Rpl22 in these processes which will potentially lead to therapeutic targets of cancer or inflammation.